Sprayable Polymer Blends for Prevention of Site Specific Surgical Adhesions

Project Summary
Adhesions are rigid, fibrous bridges that adjoin tissue surfaces as a result of ischemic conditions following
postoperative mesothelial injury. Studies have shown a 93% occurrence rate following abdominal surgery and
complications of small bowel obstruction, chronic pelvic pain, and female infertility, where treatment accounts for
over $1 billion in healthcare costs. Clinically adopted prevention strategies include a hyaluronic acid-
carboxymethylcellulose sheet-like film often described as “brittle” and “sticky” in practice, thereby rendering it
difficult to apply and inconsistent in treatment efficacy. Additional strategies include gel-based materials designed
to sustain shear forces imparted by the perpetual shifting of organs in vivo, as well as delivery of anti-
inflammatory and hemostatic therapeutics targeting non-physical pathways. Clinical translatability of solid and
gel barriers is largely impeded by either their mechanical properties or means of application, while delivery of
anti-inflammatory drugs presents issues of controlled release when topically administered. Inclusion of a targeted
therapeutic into a solid barrier host matrix with improved mechanical properties and translatable applicability,
would provide for a holistic approach to both adhesions prevention {and complications associated with intestinal
anastomosis such as intestinal fluid leakage.
Adherence and ability to conform to an injured tissue site is imperative in combinatorial design of a solid barrier
and sealant capable of effective anti-inflammatory release. Use of an elastic, surface eroding polymer as a drug
host offers a physical solution to both concerns, as we hypothesize molecules implicated in abnormal
fibrogenesis would detach from the barrier’s external surface prior to their functional time scale (Specific Aim 1).
However, ischemic conditions and a disrupted inflammatory response highlight the biological foundation of
adhesions and a pathway to an augmented treatment approach. Localized anti-inflammatory release from an
adherent polymer solid barrier could inhibit the rapid fibroblast proliferation within a fibrin matrix presented in
adhesions pathology. With evidence of enhanced receptor binding affinity, we hypothesize mimetic peptides of
apolipoprotein E (ApoE) will inhibit the secretion of pro-inflammatory cytokines noted in adhesions development
(Specific Aim 2). Evaluation of prevention efficacy is qualified through complication rate and an objective grading
scheme assessing the appearance and relative degree of difficulty required to separate the fibrous scar tissue,
while sealant efficacy will be measured via ex vivo and in vivo burst pressure models. {Due to the broadness
and large surface area of the abdominal cavity, we will qualify adhesions prevention and sealant efficacy of
surface eroding and drug releasing polymer solid barriers within the intraperitoneal (IP) space of cecal wound
mouse and porcine models (Specific Aim 3).}

Public health relevance
Project Narrative The proposed work aims to develop better anti-adhesions surgical sealants utilizing local release anti- inflammatory oligopeptides from biodegradable polymers by site specific deposition. This approach has the propensity to be a potent tool in surgery and general biomaterials fabrication. The goal of this research is to correlate material properties to in vitro and in vivo surgical sealant efficacy, leading to progress over existing clinical treatment options and improved procedural outcomes.